Harnessing type I interferon to promote lung-resident memory CD4 T cell immunity against influenza

Project Summary
Memory CD4 T cells residing at sites of infection are key orchestrators of immunity. It is increasingly clear
that key signals promoting such tissue-resident memory (TRM) cells do not overlap completely with those that
support generation of conventional memory T cell subsets. Delineating signals that optimize CD4 TRM generation
is important to improve vaccine-induced immunity against pathogens like influenza A virus (IAV) against which
antibody alone cannot confer lasting protection. Our data indicates that type I interferons (IFN) can promote a
unique activation module that optimizes the transition of anti-viral CD4 T cell effectors into TRM, and that Th1
programming, through the transcription factor T-bet, restricts the ability of cells to adopt this ‘pre-TRM’ effector
state. This proposal will breakdown key mechanisms underlying the ability of type I IFN to promote lung CD4
TRM during IAV infection and in a translational model of intranasal vaccination.
In Aim 1, we will use mouse models to differentiate how direct type I IFN signals to CD4 T cells, and indirect
effects through modulating the inflammatory environment, impact the functional and transcriptional identity of
pre-TRM effectors and ultimately shape the TRM landscape. We will also determine the extent to which T-bet
expression by CD4 T cells effects the ability of I IFN to modulate TRM priming. In Aim 2, we will determine how
IAV-primed CD4 T cells interpret type I IFN signals through signal transducer and activator of transcription
(STAT) molecules, and the extent to which specific STAT activation signatures by type I IFN change through the
kinetic window when we find memory fate to be determined. This analysis will be used to optimize strategies to
boost TRM through increasing availability of type I IFN to responding CD4 T cells. A hallmark of effective CD4
TRM responses is their rapid activation which results in control of viral titers before systemic immune responses
are initiated. As Type I IFNs have a suppressive impact on naive CD4 T cell activation, we propose that CD4
TRM are specialized to not only escape this suppressive impact during antigen encounter, but to harness type I
IFN as an acute ‘trigger’ optimizing their recall. In Aim 3 we will determine the extent to which this mechanism
operates, and how T-bet and specific STAT expression by TRM fine-tune this response.
This proposal will provide high impact mechanistic data by elucidating how type I IFN can be harnessed to
improve the generation and recall of CD4 TRM, with relevance to IAV and likely other respiratory pathogens. Our
long-term goal is develop vaccine and therapeutic strategies incorporating insights from this research to improve
durable and rapidly responsive cellular immunity in the lung.

Public health relevance
Project Narrative Vaccines against respiratory viruses can be improved by targeting the generation of memory CD4 T cells that reside long-term in the lung, but signals promoting the optimal generation of this memory subset are unclear. This proposal will delineate how type I interferon, a signature anti-viral cytokine produced in the lung, acts to promote establishment of lung-resident memory CD4 T cells during infection and vaccination. Our goal is to develop strategies to harness type I interferon to promote lung-resident memory CD4 T cells and to improve the ability of such memory cells to respond to infection.